Consequences of vaginal microbiota on IFNÃÂ³-mediated clearance of Chlamydia trachomatis

Chlamydia trachomatis (CT) infections are a major public health concern as they can adversely affect female fertility and neonatal health. While natural history studies indicate that some women spontaneously clear their infection, the physiological conditions that permit spontaneous clearance of CT remain elusive. Understand the latter is key to developing an effective vaccine that to prevent CT infection and its devastating consequences. In vitro and in vivo studies indicate that interferon gamma (IFNγ) is the primary protective cytokine against CT. IFNγ induces the host enzyme indoleamine 2,3-dioxygenase (IDO1) that degrades tryptophan, an essential amino acid for CT, which cannot synthesize tryptophan de novo. All clinical genital CT isolates have evolved a mechanism to evade the effect of IFNγ, specifically they can express a functional tryptophan synthase that salvages exogenously provided indole to generate tryptophan within the intracellular chlamydial inclusion where it is impervious to IDO1. While neither CT, nor human cells, synthesize indole, some members of the vaginal microbiome that increase greatly in number and proportion during bacterial vaginosis (BV), can do so. Thus, we hypothesize that the composition of the vaginal microbiome, and its capacity to provide indole, modulates the efficacy of IFNγ-dependent host immunity against CT. This hypothesis is supported by our existing clinical data; although all women who spontaneously cleared CT infection had high endocervical IFNγ levels, so did ~40% of women who failed to clear infection. We propose to rigorously test this hypothesis using a cohort of high-risk African-American women attending our STD clinic in New Orleans. The cohort will be stratified into groups that spontaneously clear CT infections (~28% in our cohort) or fail to clear CT infection between enrollment and return-for-treatment visits. By focusing on women who spontaneously clear infection, and the ~40% of non- clearing women who meet the threshold endocervical IFNγ levels observed in clearers, we will investigate the following objectives: 1) Determine the infection micromilieu (tryptophan/indole/IFNγ/CT load & gene expression profile) correlates of clearance; 2) Determine differences in the prevalent vaginal microbiome, and its indole- generation capacity, between clearers and non-clearers; and 3) Using a novel endocervical epithelial cell model, directly test the capacity of indole-producing microbiome members to limit IFNγ-mediated CT clearance, and evaluate the efficacy of known small molecule indole biosynthesis inhibitors to augment IFNγ-mediated CT clearance during co-infections. The outcomes from the proposed studies will provide essential information needed to design novel immunological and pharmacological approaches that improve clinical outcomes for CT- infected patients. Modeling the mechanisms used during spontaneous clearance will define the effects of co- infection on the efficacy of the host response to CT-infection. This will significantly improve patient health and welfare in light of the tremendous human and financial toll that is imposed by genital CT infections.

Public health relevance
Project Narrative Co-infections with different sexually transmitted infections are common in the sexually active population. This study will determine how normal and abnormal co-infecting vaginal microbiota can interfere with the clearance of Chlamydia trachomatis infection by creating an environment that reduces the efficacy of the patient’s immune response against Chlamydia trachomatis, which is driven by the host cytokine interferon-gamma. New knowledge gained will provide key information necessary to prevent and treat the devastating effects of chronic and debilitating chlamydial infections on reproductive health.